Medical Scientist Training Program

This proposal requests support for the Medical Scientist Training Program (MSTP) at the Vanderbilt University
School of Medicine. The program's primary goal is to identify, recruit, train, and mentor a diverse workforce of
compassionate and dedicated future physician-scientists. These Vanderbilt-trained physician-scientists will
serve critical needs in all aspects of medicine, science, industry, and government to improve human health,
reduce disparities, and improve society through leadership in biomedical research and clinical practice. Our joint
MD-PhD program is based on rigorous training in clinical medicine and scientific inquiry. Core program elements
explicitly developed for dual-degree students include a foundational biomedical course, a literature-based
seminar series, the Clinical Preceptorship Program, Seminar Series, leadership workshops, the Physician-
Scientist Speaker Series, extensive near-peer mentoring, a host of student-led institutional and community
outreach activities to give back to the community, and an annual retreat to reinforce connections, hear about
great science, and learn together. Students receive formal instruction in quantitative reasoning, responsible
conduct of research, and rigor and reproducibility threaded and reinforced throughout the curriculum. An
innovative advising college program offers opportunities for vertical integration of faculty members and both
physician-scientists in residency and MSTP trainees. Current students play key roles in student recruitment and
curriculum development. Our alumni are exceptionally accomplished which include the founding president of the
Gladstone Institute, three deans, three department chairs, 26 full professors, and 18 industry leaders. More
recent graduates still in training are in superb residencies and fellowships. The 109 current trainees come from
74 colleges and universities distributed across North America. The growth of our nationwide applicant pool
results from concerted recruiting efforts, including those focused on recruiting students from underrepresented
groups in medicine. In the current year, 595 applications have been received, from which 15 students will be
selected to enter the incoming class. The educational environment for physician-scientists at Vanderbilt
University ranked #12 in NIH funding, is outstanding and built on established strengths in biomedical informatics,
cancer biology, cell biology, clinical pharmacology, diabetes, neurosciences, toxicology, drug discovery,
genetics, chemical and physical biology, imaging sciences, microbial pathogenesis, pharmacogenomics, and
vaccine science. Newer areas of research emphasize immunobiology, inflammation and cancer, precision
medicine, quantitative systems biology, and structural biology. Based on the commitment of our leadership team,
the strength of our applicant pool, enhanced opportunities for physician-scientist training, a longstanding
institutional commitment to the education of MSTP leaders in biomedical research, and the success of our
graduates in academic medicine, this proposal requests an increase in positions to 27 for the five-year project
period.

Public health relevance
Project Narrative Our program identifies, recruits, trains, and mentors a diverse workforce of compassionate and dedicated future physician-scientists. These Vanderbilt-trained physician-scientists serve critical needs in all aspects of medicine, science, industry, and government to improve human health, reduce disparities, and improve society through leadership in biomedical research and clinical practice. The public health benefit is realized through the integrated clinical and research accomplishments of our graduates as they elucidate the basic mechanisms of disease and capitalize on these discoveries in developing new therapeutic agents and strategies.